ASCORBATE-DEPENDENT OXYGEN CONSUMPTION: A NEW FUNCTION OF THE VITREOUS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Nuclear sclerotic cataract is associated with oxidative damage to the lens proteins. Exposure of the lens to increased oxygen and loss of the gel structure of the vitreous body lead to nuclear cataract formation. Based on the distribution of oxygen in human eyes, we hypothesized that the vitreous activity consumes oxygen, which minimizes oxygen exposure to the lens. Vitreous oxygen consumption was measured using a microrespirometer fitted to an optical oxygen sensor. Vitreous ascorbate was measured spectrophotometrically and confirmed by gas chromatography/mass spectrometry. The gel state of the vitreous was assessed and related ot the rate of oxygen consumption and ascorbate concentration in samples obtained postmortem andd at the beginning of vitrectomy surgery.